Changes in Water Channel Localization to Astrocytic Endfeet with Aging

Project Summary Alzheimer's disease (AD) is an age-linked neurodegenerative disease that is the leading cause of dementia and 6th leading cause of death in the United States. It is characterized pathologically by the accumulation of amyloid β (Aβ) peptides. In the healthy brain, several mechanisms facilitate clearance of Aβ prior to pathogenic accumulation. The function of these clearance mechanisms deteriorates as an individual ages. To develop effective therapeutic strategies for patients with AD, it is important to understand the mechanisms that drive Aβ clearance, and the source of their dysfunction in the aged brain. Previous research has shown that the recently described glymphatic system is one such mechanism involved in Aβ clearance that also demonstrates age-linked dysfunction. Proper glymphatic function relies on mixing of cerebrospinal spinal fluid (CSF) with interstitial fluid (ISF) along perivascular spaces throughout the brain. This process is mediated by water flux across astrocytes that ensheathe the brain vasculature. The water channel aquaporin-4 (AQP4) supports this water flux, and is highly localized to perivascular astrocytic endfeet in the healthy brain, but loses this localization in the aging brain and with AD status. Recent research has shown that in a transgenic mouse model of AD, deletion of the Aqp4 gene in mice increases Aβ plaque accumulation and worsens cognitive impairment. In aging mice and humans with AD, while overall expression of AQP4 is maintained, perivascular AQP4 localization is lost. Importantly, whether the loss of endfoot localization of AQP4 seen in the aging brain promotes accumulation of Aβ in a similar manner to that seen in Aqp4 knockout mice is not known. The goal of this proposal is to determine the role that loss of perivascular AQP4 localization plays in Aβ accumulation, and identify cellular mechanisms that contribute to the regulation of AQP4 perivascular localization and break down in the aging brain. In Aim 1, I will assess the effect of loss of perivascular localization on Aβ clearance using a mouse model that features both a lack of perivascular AQP4 localization and spontaneous Aβ plaque formation. In Aim 2 of the proposal I will investigate whether changes in dystrophin associated complex proteins regulate perivascular AQP4 localization in the aging brain, and how loss of their expression impacts Aβ plaque burden. In Aim 3 I will investigate a second candidate regulatory mechanism for AQP4 localization, the expression of alternate AQP4 isoforms using an astrocyte-specific viral overexpression paradigm to isolate the role of each AQP4 isoform. This study will be the first to define the consequences of age-linked loss of astrocytic perivascular AQP4 localization. Additionally it will be one of the first to examine the mechanisms underlying changes in perivascular AQP4 localization in vivo. The results of this study will provide insight into AQP4 as a potential therapeutic target for AD and other neuropathologies that demonstrate an accumulation of protein aggregates including Parkinson's and Huntington's disease.

Public health relevance
Project Narrative Alzheimer's disease (AD) is characterized by an accumulation of the extracellular protein amyloid β (Aβ). Developing effective treatments for Alzheimer's disease requires understanding of the mechanisms of Aβ clearance in the healthy brain and how they deteriorate with age. The water channel aquaporin 4 (AQP4) is integral to function of the glymphatic system which aids in removal of solutes from the brain, including Aβ. Impairment of AQP4 perivascular localization with age is associated with significant decreases in Aβ clearance and impaired glymphatic function. This proposal aims to determine whether loss of perivascular AQP4 localization slows Aβ clearance, and identify the age-linked changes responsible for loss of AQP4 localization.